COMMUNITY ENGAGEMENT AND PARTNERSHIP (CEP)

Project Summary
The goal of the Community Engagement and Partnership component (CEP) is to ensure
that patients and key stakeholders are integrated into all phases of PRIHSM’s research to
promote maternal health equity. PRIHSM focuses on postpartum hemorrhage (PPH), which is
one of the most common causes of severe maternal morbidity (SMM) and maternal mortality.
PRIHSM prioritizes groups that bear the disproportionate burden of PPH, which includes Asian,
Black, Latinx and Native American individuals, those in mother-mother partnerships, and people
with limited resources and access to care. While engagement of patients and communities in
biomedical research is increasingly recognized as a best practice for promoting health equity,
there is a dearth of engagement in setting research priorities for SMM and limited understanding
of patients’ lived experiences after an obstetric complication. These limitations are even more
stark when considering issues such as severe PPH and its short and long term physical and
mental health outcomes, which are the focus of PRIHSM’s research projects. Strong,
bidirectional patient and community partnerships and effective engagement strategies are
essential for identifying and implementing the most promising interventions to reduce disparities
in SMM and maternal mortality due to PPH. Thus, CEP will create bidirectional partnerships with
patients, key stakeholders, and community-based organizations that represent people most
affected by the study outcomes through these Specific Aims: Aim 1. Build, strengthen, and
sustain bidirectional community-university partnerships focused on improving maternal health
equity; Aim 2. Integrate perspectives of patients, providers, and healthcare leadership into
PRIHSM’s research, using tailored, innovative engagement strategies such as data storytelling
and research prioritization activities to promote partner-driven solutions to improve patient-
centered outcomes. Aim 3. Develop and implement strategies to disseminate PRIHSM’s
findings to a broad audience and translate them into clinical policy and practice to promote
health equity, using innovative approaches such as mini-grants to community partners, digital
storytelling of study findings, and in-person community gatherings to facilitate maximum
engagement and uptake of key health information. Each of these aims is synergistically aligned
with our research projects and training objectives. Successful completion of these Aims will
result in strong, sustainable community-university partnerships dedicated to improving maternal
health equity and create a blueprint of best practices for successful community-engaged
research focused on maternal health.